CAMPO consortium: HPV-related anogenital disease in people with HIV

The specific aims of the parent grant, the California-Mexico-Puerto Rico (CAMPO) consortium are: 1) To
perform research focused on reducing the risk of cervical and anal cancer in men and women living with HIV
and 2) To build local capacity for research focused on reducing the risk of cervical cancer and anal cancer in
HIV-positive populations in Latin America. Two studies are currently proposed for the consortium. ULACNet-
101 is focused on defining optimal algorithms to diagnose anal and cervical high-grade squamous
intraepithelial lesions (HSIL) in women living with HIV (WLWH) and anal HSIL in men, mostly men who have
sex with men (MSMLWH). The results of various tests (cytology, HPV genotyping and methylation) will be
analyzed alone and in combination to determine the optimal diagnostic testing regimen to detect HSIL.
ULACNet-104 is designed to study the relationship between anal high-risk HPV (hr-HPV) infection and the anal
microbiome among three distinct populations of Hispanic people living with HIV (PLWH) in California, Mexico
and Puerto Rico (PR). This study is designed to take advantage of the extensive infrastructure and data
generated by CAMPO to determine how differences in the anal microbiota between Hispanic PLWH in PR,
Mexico and California may inform the role of the anal microbiome in potentiating anal HPV-related anal disease
in these high-risk populations. The specific aims of this supplement are: Aim 1: To identify optimal screening
strategies among HIV-positive women in Mexico and Puerto Rico for anal and cervical high-grade squamous
intraepithelial lesion (HSIL) detection, including cytology, HPV extended-typing and methylation markers
(ULACNet-101); Aim 2. Study the relationship between anal high-risk HPV (hr-HPV) infection and the anal
microbiome among three distinct populations of Hispanic people living with HIV (PLWH) in California, Mexico
and Puerto Rico (PR) (ULACNet-104); Aim 3. Study the relationship between anal high-grade squamous
intraepithelial lesions (HSIL) and the anal microbiome among three distinct populations of Hispanic PLWH with
anal hr-HPV infection in California, Mexico and PR (ULACNet-104). The purpose of this supplement is to allow
us to continue enrollment in ULACNet-101 and ULACNet-104 to reach our target accrual, to clean and lock
ULACNet-101 and ULACNet-104 databases, complete laboratory testing for ULACNet-101, analyze the
ULACNet-101 and ULACNet-104 data, and prepare them for publication.

Public health relevance
The CAMPO consortium is performing ULACNet-101, a study to optimize screening algorithms for the precursor lesion to anal and cervical cancer, i.e., anal and cervical high-grade squamous intraepithelial lesions (HSIL), respectively, in people living with HIV in Latin America. CAMPO is also performing a study of the relationship between the anal microbiome, anal HPV positivity and anal HSIL among different Hispanic populations living with HIV in Mexico, Puerto Rico and California (ULACNet-104). We are requesting 1 additional year of support, from August 1, 2025 to July 31, 2026 to complete these studies, with the expectation that they will contribute to more efficient screening approaches for cervical and anal cancer prevention in Latin American PLWH, and a better understanding of the role of the microbiome as a cofactor with HPV in the development of anal HSIL in these populations.